The Impact of COVID-19 on End-of-Life Care for Vulnerable Populations

Abstract
The Coronavirus Disease 2019 (COVID-19) pandemic has thus far caused 100,000 deaths in the U.S. and has
disproportionately impacted vulnerable subpopulations, including those with underlying serious illness and
those from racial and ethnic minority groups. As of June 2020, New York City (NYC) has seen 16,000 deaths
and remains the global epicenter of the pandemic. Although public health containment and mitigation policies
including social distancing, infection control, and self-quarantine are considered to have reduced transmission
of COVID-19, they also brought about significant disruption in the way individuals sought and accessed care,
particularly those with serious illness. Hospice organizations have played a key role in supporting seriously ill
patients in their homes throughout the pandemic by ensuring effective symptom management (e.g., pain and
dyspnea); psychological support for patients, caregivers, and healthcare professionals; and support for
complex decision-making. Yet there has been scant evidence on hospice practices during COVID-19 and less
guidance for hospice organizations throughout the U.S. to improve preparedness. Indeed, at the height of the
pandemic, concomitant with the surge in demand for hospice care in NYC, we experienced a shortfall in
hospice delivery, exposing latent vulnerabilities in the capacity of the existing system to respond to a crisis that
demanded a coordinated, synchronized approach. In this innovative mixed methods study, we seek to gain an
in-depth understanding of the challenges of delivering end-of-life care in NYC during the COVID-19 pandemic
triangulating the experiences of patients, caregivers, and healthcare providers. Specifically, we will link clinical
notes of patient encounters across Mount Sinai clinical programs and community hospice to create longitudinal
trajectories of patients’ end-of-life care during the pandemic to elucidate barriers in access to hospice care and
care coordination deficiencies experienced by patients and families during this time. We will augment this
information with insights from in-depth interviews of key stakeholders including frontline clinical providers,
program leadership, staff, and caregivers. Our interviews with interdisciplinary hospice personnel, will identify
new policies and practices hospices enacted in response to COVID-19, barriers and facilitators to
implementation, perceived impact, and sustainability. Finally, through a national survey of hospices, we will
determine how implementation of policy and practice changes varied across the U.S. The proposed project is
innovative for its rapid, mixed methods approach to studying a highly vulnerable population during a pandemic
to inform current and future care planning and policy, using analyses of retrospective and prospective data in
combination with qualitative interviewing. Results will contribute new scientific knowledge as to how hospices
adapted care processes to improve patient and family end-of-life care during an emergency, inform the
development of educational tools to promote emergency preparedness, and dissemination of guidance for
hospices regarding strategies and adaptations to improve end-of-life care.

Public health relevance
This proposal is relevant to public health because it examines the impact of public health containment and mitigation policies implemented during the COVID-19 crisis in the United States on the experiences of patients at the end of life and their families. Hospice is the dominant model of home-based care for those at the end of life and the proposed research will elucidate the ways in which hospices adapted their practices and implemented new policies in response to COVID-19 and in preparation for a broad range of future emergencies.